Cefixime Dose-Response in the Mouse Model of Neisseria gonorrhoeae infection

The objective of this interagency agreement is to better establish the mouse model of of gonococcal infection for testing antibiotics against gonorrhea.